DIABETES CONTROL AND COMPLICATIONS TRIAL

Mayo is one of 21 centers participating in a clinical trial examining the effects of glucose control in diabetes complications. Pts are admitted to the GCRC for improvement of intensive insulin therapy. Also involves outpatient evaluations.